Delineating NMDA Receptor Hypofunctions Role in Schizophrenia Pathophysiology

DESCRIPTION (provided by applicant): NMDAR antagonists, including phencyclidine, ketamine and MK-801, induce a psychotic reaction in human subjects that resembles many of schizophrenia symptoms leading the NMDA receptor (NMDAR) hypofunction hypothesis of schizophrenia pathophysiology. These symptoms include the positive, negative, as well as many of the cognitive deficits, including working memory. Furthermore, NMDAR antagonists also reinstate pre- existing symptoms in stabilized schizophrenia patients. Genetic studies have offered further credence to this theory. For instance, a NR1 hypomorph mouse, in which expression of NR1 subunit protein is reduced to 5- 10%, displays deficits in social interaction and impairment in prepulse inhibition of acoustic startle reflex. Yet, it remains to be determined in which developmental stage and/or in which brain cell-types/areas is NMDAR hypofunction necessary to induce schizophrenia-like behaviors. We recently demonstrated that a restricted deletion of NMDAR in corticolimbic interneurons from postnatal 2nd week was sufficient to trigger several behavioral and pathophysiological features in mice that resemble human schizophrenia. Therefore, it provided strong experimental support for the long-standing hypothesis that NMDAR hypofunction in cortical interneurons is a primary site of schizophrenia pathogenesis. However, many genes encoding the NMDAR complex proteins, such as neuregulins, are expressed in both excitatory and inhibitory neurons in the cortex. If the mutation was introduced in these genes, NMDAR hypofunction could occur in every cell including excitatory neurons. Furthermore, it is still unclear which developmental stage is the sensitive period to NMDAR hypofunction. Finally, it is crucial to identify what occurs in the NR1-deleted interneurons and which downstream signaling cascades/circuitries are activated or suppressed following NMDAR deletion. To address these questions using transgenic mice, two major overlapping areas to be investigated in this project are: 1. Define the cell-types and sensitive period for NMDAR hypofunction critical for the manifestation of schizophrenia-like phenotypes. It is critical to narrow down the boundary conditions of NMDAR hypofunction, in order to delineate the downstream pathways of NMDAR hypofunction and to determine which pathways are responsible for later development of the disease. 2. Determine the cellular events that follow NMDAR hypofunction during the sensitive period. It will be crucial to delineate subsequent molecular, cellular and network events following NMDAR hypofunction, in order to develop the new treatments targeted to NMDAR hypofunction for human psychiatric illnesses. These findings derived from this work will yield new insights into the cortical GABAergic interneuron-related pathogenesis and its treatment of schizophrenia.

Public health relevance
PUBLIC HEALTH RELEVANCE: Schizophrenia, one of the most chronic and disabling mental disorders, is a major focus of research at the National Institute of Mental Health (NIMH). More than 2 million Americans are affected by schizophrenia in any given year, and only one in five recovers completely. The illness, which may impair a person's ability to manage emotions, to socially interact with others, and to think clearly, typically develops in the late teens or early twenties. Symptoms include hallucinations, delusions (positive symptoms), disordered thinking (cognitive symptom), and social withdrawal (negative symptom). During the last two decades, research has led to considerable advances in the treatment of schizophrenia -- primarily in the development of several new medications with fewer side effects. However, the new drugs still insufficiently treat some symptoms, especially cognitive and negative symptoms. Many people with schizophrenia continue to suffer chronically or episodically throughout their lives. In search for better treatments, more intense research needs to be continued to determine the causes and disease process of schizophrenia. This project addresses one of the major pathophysiology theories of schizophrenia - glutamatergic NMDA receptor (NMDAR) hypofunction theory. It is well known that the drugs that block NMDAR channels also evoke psychotomimetic action in healthy human subjects that mimics schizophrenia symptoms. Therefore, NMDAR hypofunction has long been implicated in the pathogenesis of the disease symptoms. However, its underlying mechanisms have remained a mystery until we recently reported that NMDAR hypofunction at cortical and hippocampal GABAergic interneurons are sufficient to elicit the schizophrenia-like phenotypes in mice. The objective of this project is, based on our own finding, to deeper our understanding of the mechanisms of NMDAR hypofunction theory. This project might play an important role in developing new therapeutic targets and define the requisite time of intervention. __SpecificAimsTextDelimiter__ SPECIFIC AIMS: The administration of glutamatergic NMDA receptor (NMDAR) antagonists to human subjects elicits core symptoms of schizophrenia, implicating hypofunction of NMDARs in the disease process. However, identifying sensitive periods and potential cell-types of NMDAR hypofunction has proven elusive. The first strong evidence that NMDAR hypofunction occurs in cortical GABAergic interneurons during postnatal development was provided by our transgenic mice that lacked an indispensable subunit, NR1(Grin1), of NMDARs in cortical and hippocampal parvalbumin (PV)-positive interneurons (Belforte et al, 2010). The mutant mice displayed several schizophrenic-like phenotypes, including deficits of prepulse inhibition (PPI) and spatial working memory (cognitive-like symptoms), exacerbated amphetamine-induced dopamine release in ventral striatum (positive- like symptoms), and impaired evoked-gamma band local field potential (LFP) oscillation in the cortex. Interestingly, NR1 deletion in the same GABA neurons failed to produce such phenotypes when the deletion was introduced after adolescence, suggesting existence of a 'sensitive period' for NMDAR hypofunction. Thus, it appears that the dysregulation of GABAergic neurons is not solely attributable to NR1 deletion. Rather, the NR1 deletion may impair the postnatal maturation of GABAergic neurons and, in the absence of proper GABAergic inhibition, the refinement of cortical circuitry may be impeded. However, a more rigorous measure of spatial (cell-types) and temporal windows of NMDAR hypofunction remains to be determined. Further, the cellular and neuronal events downstream from NMDAR hypofunction during the sensitive period responsible for the elaboration of schizophrenia pathophysiology need to be delineated. Our long-term goal is to identify the critical mechanism(s) that regulate postnatal maturation of corticolimbic interneuron circuitry and to specify how abnormalities in these systems lead to mental illnesses. The objective of this application, which is the next step in pursuit of that goal, is to determine the cell-types (e.g., excitatory neurons or parvalbumin (PV)-positive interneurons) in which NMDAR hypofunction is critical for the emergence of schizophrenia-like phenotypes in mice. Furthermore, we plan to determine the downstream cellular and network events that are critical for this phenomenon. The central hypothesis is that NMDAR hypofunction in PV neurons alters their presynaptic GABA release property, thereby inducing deficits in coordinated inhibition of postsynaptic principal neurons. This may in turn result in impaired synchronized firing of the cortical networks, impaired gamma oscillations, and subsequent subcortical dopamine dysregulation. Therefore, it is postulated that certain cellular mechanisms following NMDAR hypofunction in PV neurons prior to maturation is crucial for the later development of schizophrenia. The rationale for the proposed research is that identifying cellular events that follow NMDAR hypofunction in specific cell-types during the sensitive period will deepen our understanding of the schizophrenia disease process and help understand why symptoms arise mainly after adolescence. This information might play an important role in developing new therapeutic targets and define the requisite time of intervention. We plan to test our central hypothesis and accomplish the objective of this application by pursuing the following two specific aims: Aim 1: Define the cell-types and sensitive period for NMDAR hypofunction critical for the manifestation of schizophrenia-like phenotypes Our working hypothesis is that NMDAR hypofunction in corticolimbic PV neurons during the sensitive period is responsible for the majority of schizophrenia-like phenotypes manifest in the adult. Therefore, we postulate that a NR1 knockout selectively in cortical excitatory neurons (in G35-3-Cre/NR1 KO mutant mice) would not show robust schizophrenia-like phenotypes (Study #1.1). Furthermore, we hypothesize that NR1 deletion specifically in PV neurons by postnatal 4th week (in PV-Cre/NR1 KO mutant mice) will also trigger robust schizophrenia- like phenotypes (Study #1.2). Aim 2: Determine the cellular events that follow as a consequence of NMDAR hypofunction during the sensitive period Our Preliminary Results suggest that uncoordinated firing of cortical pyramidal neurons is a key event in the development of schizophrenia-like phenotypes (in Ppp1r2-Cre/NR1 KO mutant nice). We hypothesize that this event could be caused by an impaired evoked GABA release at presynaptic terminals of NMDAR-deleted interneurons during the sensitive period. This project is innovative, because it employs unique transgenic animal models to provide new knowledge about the NMDAR hypofunction theory of schizophrenia pathophysiology. It is our expectation that the findings derived from this work will yield new insights into the cortical GABAergic interneuron-related pathogenesis of schizophrenia. This in turn may lead to the development of new treatments targeted to particular cellular pathways for human psychiatric illnesses.